A Notch-mediated fibrogenic program drives treatment failure in rheumatoid arthritis

Project Summary/Abstract:
A key unmet need in the treatment of rheumatoid arthritis (RA) is to understand the cellular mechanism
underlying treatment failure. Recent studies have implicated joint fibroblast activation and fibrosis in treatment-
resistance RA, yet the mechanism underlying synovial fibrogenesis in RA remains poorly understood. We now
have data that indicates Notch signaling controls a fibrogenic program through regulation of transforming
growth factor beta (TGF-β) signaling. Single-cell and spatial transcriptomic profiling of RA synovia revealed
expansion of fibrogenic programs around Notch-activated stroma. The immediate goal of this project is to
define the origin of synovial fibrogenesis and its impact on joint inflammation and treatment response in RA.
The long-term goal of the project is to define targeting fibroblasts as a novel adjuvant therapy in RA. In pursuit
of these findings, we propose 3 complementary aims to define the role of Notch-driven fibrogenesis in
treatment failure in RA.
Aim 1. Define a Notch-driven fibrogenic transcriptional program in synovial fibroblasts. This aim
seeks to elucidate the molecular sequence of the fibrogenic program in synovial fibroblasts. Our goal is to
demonstrate the molecular mechanism by which Notch signaling regulates TGF-β signaling in synovial
fibroblasts. We will employ genetic perturbation via CRISPR/cas9 and transcriptomics to define the role of
TGFB1 and TGFB3 in the Notch-mediated fibrogenic program. Next, we will apply high-resolution transcript
mapping to define the spatial regulation of the fibrogenic program.
Aim 2. Determine the consequence of a Notch-driven fibrogenic program on treatment
outcomes. We hypothesize that a Notch-mediated fibrogenic program is associated with a poor treatment
outcome in RA. We will apply spatial transcriptomics to pre- and post-treatment synovial biopsies to
characterize baseline fibroblast phenotypes and evaluate for correlation between longitudinal shifts in fibroblast
phenotypes and treatment response. We will validate our findings using an independent cohort of treatment-
naive RA biopsies. We hypothesize fibrogenic fibroblasts predict treatment failure.
Aim 3. Define the effect of Notch levels on inflammatory and fibrotic niche formation. The focus
of this aim is to gain insights into how differing levels of Notch signaling lead to distinct stromal environments
and their impact on inflammatory phenotypes in RA. We hypothesize a low stromal Notch level facilitates
lymphocyte aggregation while a high stromal Notch level induces fibrinogenesis (Fig. 1). We will test this
hypothesis by utilizing two synovial organoid systems we developed: 1) a cellular reconstitution, micromass-
based organoids, and 2) RA patient-derived organoids.

Public health relevance
Project Narrative: This study aims to understand the cellular basis of treatment failure in rheumatoid arthritis. We identified Notch signaling as a crucial regulator of joint tissue fibrosis. Understanding how Notch signaling initiate fibrogenesis and alters the inflammatory architecture of RA joints may provide new therapeutic strategies to prevent joint fibrosis and enhance RA treatment response.